NLRP3 inflammasome Regulation of Bone Resorption

DESCRIPTION (provided by applicant): The Nod Leucine rich Repeat with a Pyrin domain 3 (NLRP3) inflammasome is an intracellular protein complex responsible for the maturation of interleukin (IL)-1β and IL-18. Gain-of-function mutations of NLRP3 cause neonatal-onset multisystem inflammatory disease (NOMID). NOMID patients produce excessive amounts of IL-1β, and exhibit skeletal deformities and osteopenia, suggesting that constitutively activated NLRP3 (NOMID NLRP3) significantly impacts bone remodeling. The finding that arthropathic lesions in these patients are refractory to IL-1 targeted therapy suggests that IL-1 production may not be the only mechanism of NOMID NLRP3 action in the skeleton. Indeed, this inflammasome is also involved in the cleavage of poly(ADP-ribose) polymerase 1 (PARP1), a novel mechanism of NF-κB co- activation, and osteoclast (OC) development. However, whether osteopenia per se in NOMID patients is refractory to IL-1 inhibitors is still unclear. We find that mice globally expressing NOMID NLRP3 mimic the human NOMID syndrome as they over-produce IL-1β and diminished bone mass. Further preliminary data suggest a broader role of this inflammasome in bone remodeling. First, mice expressing NOMID NLRP3, specifically in myeloid cells or in OC also have low bone mass, suggesting an OC lineage action of this inflammasome. Second, NLRP3 inflammasome promotes PARP1 cleavage and OC formation, while PARP1 knockdown inhibits OC formation. This suggests that inflammasome promotion of PARP1 cleavage may be an alternative mechanism of bone resorption over IL-1β production. Finally, bone matrix degradation products activate NLRP3, and stimulate OC formation, implying that this inflammasome may be active in all states of high bone turnover. Thus, our preliminary data suggest that NLRP3 inflammasome activation is not restricted to inflammatory conditions, and may represent a fundamental positive feedback loop that amplifies bone resorption. The central hypothesis of this proposal is that the NLRP3 inflammasome is a multifunctional regulator of bone resorption in inflammatory and non-inflammatory conditions characterized by high bone turnover. To test this hypothesis, we will use mouse genetic models and human cell systems to: 1) Define the role of PARP1 and IL-1β in bone resorption caused by NOMID NLRP3 inflammasome; 2) Investigate the role and the mechanisms of activation of this inflammasome in non-inflammatory conditions of high bone turnover. Upon completion, this project will establish that this inflammasome plays a significant role in inflammatory and non-inflammatory bone loss, thus positioning it as a potential therapeutic target for diseases of bone loss.

Public health relevance
PUBLIC HEALTH RELEVANCE: The goal of this project is to understand the role of NLRP3 in bone loss. If this protein plays a role in bone loss, the future research would be to find a way to block the function of this protein in people with bone diseases. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The Nod Leucine rich Repeat with a Pyrin domain 3 (NLRP3) inflammasome is an intracellular protein complex responsible for the maturation of interleukin (IL)-1β and IL-18 (1). Autosomal dominant gain-of- function mutations of NLRP3 cause neonatal-onset multisystem inflammatory disease (NOMID). NOMID patients produce excessive amounts of IL-1β and IL-18, and subsequently develop systemic inflammation associated with skeletal malformations and short stature (9). Importantly, low bone mass is present in 85% of NOMID patients (9), suggesting that constitutively activated NLRP3 (NOMID NLRP3) inflammasome significantly impacts bone remodeling. The clinical reports that bone lesions in these patients are refractory to IL-1 targeted therapy (11,12) suggest that IL-1 over-production may not be the only mechanism of NOMID NLRP3 inflammasome action in the skeleton. Indeed, this inflammasome is also involved in the cleavage of poly(ADP-ribose) polymerase 1 (PARP1), a novel mechanism of NF-kB co-activation (2,3), and osteoclast (OC) regulation (4,5). However, whether osteopenia per se in NOMID patients is refractory to IL-1 inhibitors is still unclear. We find that mice globally expressing NOMID NLRP3 (NOMIDGlobal mice), recapitulate the human NOMID syndrome as they over-produce IL-1β, develop systemic inflammation, and exhibit growth retardation and severely diminished bone mass (10). Further preliminary data suggest a broader role of the inflammasome in bone remodeling. First, mice expressing NOMID NLRP3, specifically in myeloid cells or in OC, have low bone mass as do NOMIDGlobal mice, suggesting an OC lineage action of the inflammasome. Second, this inflammasome promotes PARP1 cleavage and OC formation, while PARP1 knockdown inhibits OC formation. This suggests that inflammasome promotion of PARP1 cleavage may be an alternative mechanism of bone resorption aside IL-1β production. Finally, bone matrix degradation products activate NLRP3 inflammasome, and stimulate OC formation, implying that this inflammasome may be active in all states of high bone turnover. Thus, our preliminary data suggest that NLRP3 inflammasome activation is not restricted to severe inflammatory conditions, and may represent a fundamental positive feedback loop that amplifies bone resorption. The central hypothesis of this proposal is that the NLRP3 inflammasome is a multifunctional regulator of bone resorption in inflammatory and non-inflammatory conditions characterized by high bone turnover. Thus, the following Specific Aims are proposed: Specific Aim 1: Define the role of PARP1 and IL-1β in bone resorption caused by constitutively activated NLRP3 (NOMID NLRP3) inflammasome. Hypothesis: NOMID NLRP3 inflammasome stimulates bone resorption via PARP1-cleavage and IL-1β- dependent mechanisms. We will prevent either PARP1 cleavage or IL-1β signaling in mouse NOMID models. We will also inhibit these pathways in human NOMID cells of the OC lineage. These studies will not only elucidate the mechanisms of increased bone resorption in NOMID, but also help clarify whether or not bone resorption per se in NOMID patients is refractory to IL-1 drugs. Specific Aim 2: Determine the role and the mechanisms of activation of the NLRP3 inflammasome in non-inflammatory conditions of high bone turnover. Hypothesis: NLRP3 inflammasome is a key regulator of bone resorption in non-inflammatory conditions of high bone turnover. We further hypothesize that degradation of the bone mineral phase generates signals that activate the NLRP3 inflammasome and perpetuate bone resorption. We will determine whether and to what extent Nlrp3 ablation prevents bone resorption in mouse models of hyperparathyroidism and estrogen deficiency, two different and clinically relevant conditions characterized by accelerated bone resorption. We will also use models of altered bone mineralization to determine the requirement of bone mineral for NLRP3 inflammasome activation and bone resorption. Distinction between mechanisms of inflammatory and non- inflammatory bone loss is relevant for therapeutic intervention. This project will shed light on the mechanisms of bone loss in NOMID patients, and establish the NLRP3 inflammasome as an important mediator of bone loss in its non-mutated state. We expect that the NLRP3 inflammasome will play a significant role in inflammatory and non-inflammatory bone loss, thus positioning it as a potential therapeutic target for diseases of bone loss.